Graduate Training in Neuroscience at the University of Mississippi Medical Center

PROJECT SUMMARY

The Program in Neuroscience (PIN) is a PhD-awarding program at the University of Mississippi Medical Center (UMMC). The purpose of the Program is to train the next generation of neuroscience researchers to become confident and independent scientists with a broad understanding of the neurosciences and the ability to effectively communicate that knowledge. The Program in Neuroscience is interdepartmental with 33 faculty members, 22 serving as preceptors, across 11 departments. Trainees receive a broad foundational training in neuroscience as well as biochemistry and molecular biology, statistics and data analysis, and scientific writing and presentation. Additionally, all student receive training in responsible conduct of research and professional skills. Faculty are well-funded and research expertise runs the breadth of modern neuroscience from molecular and cellular to organismal and behavioral studies. During rotations in their first two years, students are exposed to a broad array of techniques and approaches, laboratory environments, and research areas. Students receive substantial mentoring and oversight and have a robust academic support system. The Program in Neuroscience receives strong institutional support through the School of Graduate Studies in the Health Sciences including considerable stipend and tuition support as well as student travel allowances for conference attendance and professional skills development. The Program in Neuroscience prides itself on not only imparting strong scientific knowledge and research skills, but also in developing the complete scholar with a solid grounding in professional skills ready to take the next steps as an independent scientists.

Public health relevance
PROJECT NARRATIVE The University of Mississippi of Medical Center Program in Neuroscience trains and supports students to become the independent research scientists. It is a comprehensive training program focused on all aspects of the brain and nervous system from the molecular to behavioral and encompassing basic science, preclinical, and translational aspects. We aim to mold students that are rigorous research scientists and strong communicators with robust foundational knowledge of neuroscience ready and able to advance biomedical research and improve human health.